Coordination center for the NIDCD National Human Ear Resource Network

Project summary
The purpose of this proposal is to create and establish our laboratory as a Coordination Center for the NIDCD
National Human Ear Resource Network, which will streamline and facilitate communications between the NIDCD
staff and temporal bone laboratories, as well as coordinate scientific collaborations and services provided by the
Network laboratories. The Coordination Center will have multiple purposes: (1) creation of a dedicated website
for the NIDCD National Human Ear Resource Network; (2) organize, host, and chair several meetings, which
include recurring teleconferences, steering committee meetings, and virtual seminar series; (3) liaise with the
NIDCD staff and the Network’s PIs to ensure achievement of the activities proposed in the parent application;
and (4) work with the NIDCD Temporal bone Registry to streamline the updating of the registry and coordinate
uploading temporal bone images to a database. The Coordination Center will have two main missions: to create
an inclusive environment for all members of the Network, ensuring ample and equitable participation from all
institutions, and to become a "port of entry" for researchers and scientists to access the services provided by the
NIDCD Network. With the new Network of 5 labs in place, we have a vision for a broad, well-diversified, inclusive
research community for temporal bone research. The parent proposal provides temporal laboratories with
funding dedicated to support basic operations and further expand their research. Additional coordination of
efforts will accelerate progression of temporal bone research. We, at the Otopathology laboratory at the
University of Minnesota (UMN), envision that the creation of a university and laboratory-agnostic Coordination
Center (under the NIDCD umbrella) is essential to promote inclusivity and encourage equal contributions by all
network members while also attracting a diverse group of additional research groups and institutions. Through
the Coordination Center, each temporal bone laboratory will be an important piece within the NIDCD Network
machinery. Ultimately, the Coordination Center will allow bridging the gaps between individual laboratories to
assemble the NIDCD temporal bone Network (as envisioned by the NIDCD), providing a wider scientific
community with the unique resource of temporal bone tissue research. The otopathology laboratory at the
University of Minnesota has many advantageous attributes that qualify us to become the Coordination Center
for the NIDCD Network: (1) experience in the missions of the NIDCD registry, acquired by being an active
member of the Registry since its inception; (2) advantageous location (the only otopathology laboratory located
in the Midwest); (3) our large track record of scientific and educational efforts that were coordinated and
conducted with other temporal bone laboratories; (4) a wide number of technological solutions that allows hosting
and conducting state-of-the-art meetings and conferences; and (5) a critical knowledge on the creation of a
virtual temporal bone laboratory, acquired through setting up a digital laboratory in “Elevator”.

Public health relevance
Project narrative: We aim to create a Coordination Center for the NIDCD National Human Ear Resource Network. The Coordination Center will have two main missions: to create an inclusive environment for all members of the Network, ensuring ample and equitable participation from all institutions; and to become a "port of entry" for researchers and scientists across the nation (and the world) to access the services provided by the NIDCD Network. The Coordination Center will be a critical resource for ensuring that the missions or the Network are being met by coordinating efforts between members (otopathology laboratories) and the NIDCD staff.